New York Regional Inborn Errors of Immunity Resource Initiative League (NY-ROYAL)

Project Summary
Inborn errors of immunity (IEI) are disorders of the immune system which are individually rare but collectively
affect 1 in 10,000 individuals. Definitive genetic diagnosis is of essence for timely genetic counseling and clinical
care. Such care may involve bone marrow transplantation, gene therapy or precision pharmacotherapeutics, all
of which can be curative. The recent advancement of genome sequencing in quality and price has led to an
increased rate of discovery of what are now over 400 causal genes underlying IEIs. However, about three
quarters of IEI sequencing yields either variants of unknown significance (VUSs) in one of the 400+ genes or
require discovery of novel causes. This leads to delays in diagnosis and treatment, especially since most of
these VUSs cannot be validated using clinically available assays. As sequencing panels are increasingly utilized
and being covered by insurance, the rate of genetic data production outpaces indiividuals’ capacity to interpret
it. The primary purpose of this proposal is to build a regional resource which would formalize case review
process, match providers and their patients carrying VUSs with research laboratories capable of targeted
functional evaluation and/or bioinformatic assessment, thereby leading to VUS reclassification, diagnosis and
treatment. It also will infuse research enterprises with clinically significant biological questions. We propose to
streamline this process in the NY region by building a 1) patient referral platform and database where
providers will be able to input deidentified patient clinical information alongside the associated genetic data (IEI
gene panels, WES, and WGS sequencing), 2) a multidisciplinary review process where submitted data will
be evaluated by an expert review panel at the forefront of IEI gene discovery and functional validation on a
regular basis who will work to disposition relevant VUSs for 3) functional characterization by a collaborating
expert team followed by 4) result reporting, VUS reclassification and its inclusion in the national clinically relevant
genetic variation database. This multidisciplinary diagnostic NY regional immunology resource is key to
supporting the discovery and functional characterization of novel IEI associated genetic variants. This resource
will serve future, more broadly applied integration of genomics, artificial intelligence/machine learning, rapid
functional assessment and precision medicine.

Public health relevance
Project Narrative Inborn errors of immunity (IEI) are genetic disorders of the immune system affecting over 400 genes, with new defects discovered at a rapid rate. As the IEI gene panels, WES, and WGS sequencing are increasingly used, about 75% of IEI sequencing yields no diagnostic variants, but do yield variants of unknown significance (VUSs) in one of there 400 genes or novel candidate genes, which require functional characterization for definitive genetic diagnosis. We propose to build a regional resource which will lead to an increase in diagnostic rate and an expansion of research enterprises with clinically significant biological questions.